NEUROBIOBANK (NBB) NBB COMMUNICATIONS AND OUTREACH SERVICES. 09/30/2022 TO 09/29/2026.

The National Institutes of Health (NIH) NeuroBioBank (NBB), supported by the National Institute of Mental Health (NIMH), National Institute of Neurological Diseases and Stroke (NINDS), National Institute
on Aging (NIA), National Institute on Drug Abuse (NIDA), and the Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD) is a centralized brain and nervous system tissue resource, composed of six Brain and Tissue Repositories (BTRs) that are federated through an IT
Portal (www.neurobiobank.nih.gov). The BTRs acquire, process and store postmortem brain and nervous system tissue donated by individuals from across all 50 states and distribute to researchers worldwide, facilitating an increase in knowledge about the etiology and pathogenesis of neurological, psychiatric, neurodevelopmental, and substance use disorders.
This contract is to create the NBB Communications and Outreach Services to support the BTRs. This contract is part of a strategy by the NIH to promote awareness of postmortem brain donation and the need to increase the pool of available donors to advance research and drug discovery studies into the
brain in health and in diverse brain disorders.